Developmental Funds

DEVELOPMENTAL FUNDS: PROJECT SUMMARY
From 2018 to 2022, the Georgetown Lombardi Comprehensive Cancer Center (LCCC), guided by the LCCC
Strategic Plan and inspired by our catchment area priorities, distributed $1.011M of CCSG developmental funds
to support pilot research projects, aiming to support innovative research with an emphasis on strategic priorities
for multi-PI collaborations that include cross-consortium collaborations. Other sources of funds, totaling $2.1M,
included alternative grant mechanisms and philanthropy, and were used to support career development,
specialized pilot projects and shared resource development in concert with LCCC’s Strategic Plan. CCSG
support of $1.011M was provided to 24 research projects and 1 designated team science initiative from 2018-
2022, yielding an 11.8:1 Return On Investment (ROI) based on $11.93M (total direct costs) in grant funding, with
9 publications. Non-CCSG developmental funds ($865,750) have supported career development research (ACS
IRG), breast cancer, GI cancer, immunotherapy research, cross-consortium collaborative research, shared
resource vouchers, yielding an ROI of 13.9 to date, based on that category of investments. Additional funds have
supported the purchase of equipment, such as a mass spectrometer in the Mass Spectrometry and Analytical
Pharmacology Shared Resource and a slide scanner for the Histopathology and Tissue Shared Resource. In
the proposed project period we intend to prioritize CCSG funds to support pilot projects that include
transdisciplinary teams from basic, clinical, and population science, and focus on catchment area issues. We
also plan to invest developmental funds in pilots that relate to (1) radiation oncology; (2) surgical subspecialties;
and (3) transdisciplinary collaborations between investigators in the Cancer Prevention and Control Program
and either the Cancer Cell Biology Program and/or the Cancer Host Interactions Program. Additional non-CCSG
funds will help further build cross-consortium collaborations and support recruitments needed to advance our
strategic priorities.